Dual anti-leukemic and cardio protective role for ROCK

PROJECT SUMMARY / ABSTRACT
Targeted tyrosine kinase inhibitor (TKI) such as those approved for the treatment of Philadelphia positive (Ph+)
chronic myelogenous leukemia (CML) and Ph+ acute lymphocytic leukemia (ALL) (i.e. Imatinib, Dasatinib,
Nilotinib and Ponatinib) have revolutionized the treatment. Unfortunately, long-term treatment with Imatinib (1st
generation TKI) and Dasatinib (2nd generation) for CML and ALL patients has led to the development of drug
resistance, mostly due to acquisition of new mutations. To circumvent drug resistance encountered with first and
second generations, the third generation TKI Ponatinib was developed. Although it is highly effective for
refractory CML and ALL, severe cardiotoxicity (CTX) and vascular adverse events (VAEs) have been reported
similar to that reported with Anthracyclines (ANT) in cancer therapy. Thus, both non-specific therapies such as
doxorubicin (DOX), an ANT prototype, and targeted therapies such as second and third generation TKIs result
in CTX during acute myelogenous leukemia (AML), CML and ALL treatment. The long-term objective of this
proposal is to develop novel approaches to mitigate TKI-induced CTX in patients undergoing treatment for AML,
CML and ALL. In an effort to achieve these objectives, we propose a multi-PI application involving Drs. Kapur
and Shi, who have complementary expertise in studying hematologic malignancies and cardiac functions under
stresses, respectively. Their expertise will be utilized to assess new strategies for cardioprotection in the context
of both leukemia and CTX with a focus on understanding the molecular and/or cellular mechanisms that underlie
the development of cancer therapy-induced severe adverse sequelae. Importantly, the two PIs have an
established history of working together as noted by eight co-authored publications including in “CANCER CELL”,
“CELL” and additional journals. Drs. Shi and Kapur have been studying the role of Rho kinases (ROCK) in
leukemogenesis and in regulating cardiac function(s) for years; Dr. Shi has identified a critical role for ROCK
inactivation in protecting cardiac structure and functions under various stresses and Dr. Kapur has identified an
anti-leukemic role for ROCK inactivation. A major objective of this proposal is to study if inhibition of ROCK
activity during the treatment of CML and ALL with TKIs can mitigate CTX but retain potent anti-leukemic
properties. Preliminary evidence suggests that global inhibition of ROCK1 in mice protects cardiomyocytes
(CMs) from chemotherapy-induced apoptosis and impaired autophagy. Interestingly, inhibition of ROCK activity
in leukemic cells (both AML and CML) results in growth inhibition and apoptosis. We hypothesize that inhibiting
ROCK activity during CML and ALL treatment with accumulating dose of potent second and third generation
TKIs will be cardioprotective and retain high anti-leukemic activity.

Public health relevance
PROJECT NARRATIVE Cardiac toxicity and vascular occlusion are two major side effects in leukemia patients treated with chemotherapy and targeted therapy. Overall goal of the project is to assess the role of ROCK kinase in mitigating and reversing this type of toxicity.